Data Management/Statistics

For this TMRC application we propose to set up a data management core faciity to effectively manage standardized data collecfion that will provide: 1) uniform structure forthe collecfion, entry, security, quality control, storage, formatfing, backup and distribution of all data collected for all 3 projects. 2) Perform/consult on all data analyses of primary and secondary endpoints to fulfill the TMRC scienfific goals. Likewise through this Core we propose to substanfially upgrade software and equipment devoted to data management and analysis to conform with the fast pace in the development of technology. Through this core, SOPs will be developed for 1) study ID assignments, 2) design and prinfing of barcoded labels, 3) the design of data forms, 4) the design of databases, 5) the design of backup strategies, 6) the design of data security features, and 7) the design of down-stream formatting of data. RELEVANCE (See instructions): We firmly believe that effecfive data management begins prior to the collecfion of a single data element. Establishing a Core facility to service data handling for all 3 projects offers the best strategy to achieve this goal.